Protective roles of CD180 and NOD1 in the protective immunity against cerebral Toxoplasma infection

The molecules that recognize pathogen-associated molecular patterns (PAMPs) are an important first-line
defense system to recognize an invasion and proliferation of pathogens and promptly activate the protective
immunity. Toxoplasma gondii, an intracellular protozoan parasite, establishes chronic infection in the brain, and
reactivation of this chronic infection can cause sever encephalitis. For preventing this disease, the immune
system needs to rapidly detect proliferation of tachyzoites (the acute stage form) in the brain during the early
stage of reactivation of the infection for effectively activating the protective immunity. Thus, the defense system
that recognizes the PAMPs-recognizing molecules expressed in the brain should play crucial roles in readily
detecting tachyzoite growth and activating the protective immunity during the early stage of reactivation of the
infection. We previously identified that IFN-g is required for the protective immunity to prevent reactivation of
cerebral T. gondii infection. Our studies also identified that microglia, tissue-resident macrophages in the brain,
produce IFN-g in response to cerebral tachyzoite growth, and that production of IFN-g by brain-resident cells is
critical for promptly activating cerebral innate immunity and facilitating migration to T cells into the brain to
prevent reactivation of the infection. Notably, our recent study revealed that cerebral mRNA levels for two
PAMPs-recognizing molecules, CD180 and nucleotide oligomerization domain 1 (NOD1), markedly increase in
association with IFN-g production by brain-resident cells during reactivation of T. gondii infection. CD180 is
expressed on microglia and classified as one of sensomes of microglia for detecting endogenous ligands and
microbes in both humans and mice. Therefore, it would be possible that CD180 recognizes tachyzoite-derived
molecules and activates IFN-g production by microglia. Macrophages also express CD180, and they also play
important roles in preventing cerebral tachyzoite growth. CD180 has also been shown to upregulate TNF-a
expression in macrophages in a bacterial infection. TNF-a, in addition to IFN-g plays important roles in
inhibiting cerebral tachyzoite growth. Thus, it is possible that CD180 activates IFN-g and TNF-a production by
microglia and macrophages against tachyzoite growth and promptly activate both innate and T cell-mediated
protective immunity to prevent reactivation of T. gondii infection. NOD1 recognizes peptidoglycan moieties
from Gram-negative bacteria and single stranded RNA from various viruses. A recent study identified that
NOD1 is required for restricting replication of Trypanosoma cruzi, an intracellular parasite, in IFN-g-activated
macrophages. In addition, mice deficient in both NOD1 and NOD2 have decreased IFN-g levels in their plasma
during cerebral malaria. NOD1 also enhances cerebral TNF-a production in intracerebral haemorrhage. Thus,
the proposed studies focus to determine whether CD180 (Aim 1) and NOD1 (Aim 2) expressed in microglia
and macrophages play important roles in activating their production of IFN-g and TNFa and promptly activating
both innate and T cell-mediated protective immunity to prevent reactivation of T. gondii infection.

Public health relevance
The molecules that recognize pathogen-associated molecular patterns (PAMPs) are an important first-line defense system to promptly recognize an invasion and proliferation of pathogens and activate the protective immunity to prevent the pathogen growth. Whereas reactivation of infection with Toxoplasma gondii in the brain can cause sever encephalitis, the roles of the PAMPs-recognizing molecules in the brain in the host defense against reactivation of the infection remain unknown. Since our recent study revealed marked increases in cerebral expression of two PAMPs-recognizing molecules, CD180 and NOD1, in the protective immunity during reactivation of the infection, the proposed studies focus to elucidate the roles of CD180 and NOD1 in the protective immunity to prevent reactivation of cerebral infection with T. gondii.